Screen for Ras inhibitors

BACKGROUND. Mutations in the KRAS oncogene occur in approximately 30% of cancer yet little therapeutic options exist for the treatment of these cancers. Various strategies to target KRAS protein have not been successful in the past. PURPOSE. In this project we aim to take a different approach to discover inhibitors of the KRAS oncoprotein. We are using high-throughput screening of a small molecule library to identify compounds that may cause the degradation of the KRAS protein. SIGNIFICANT MATERIALS AND METHODS. A cell-based assay was developed to measure the effect of small molecules on KRAS protein levels in a high-throughput format. FY2014 ACCOMPLISHMENT. We have completed the screen against 2,000 compounds in collaboration with NCATS. We have identified candidate compounds with desired activity, and our manuscript describing this study has been accepted for publication.